Learning novel structure across time and sleep

Project Summary
Acting adaptively requires quickly picking up on structure in our environment (e.g., the layout of a city you are
visiting for the first time) and storing the acquired knowledge for effective future use (efficient navigation on
subsequent visits). Dominant theories of the hippocampus have focused on its ability to encode individual
snapshots of experience, but we and others have found evidence that it is also crucial for finding structure across
experiences (understanding the relationship between different views of the same distant building). The
mechanisms of this essential form of learning have not been established. We have developed a neural network
model of the hippocampus instantiating the theory that one of its subfields can quickly encode structure using
distributed representations, a powerful form of representation in which populations of neurons become
responsive to multiple related features of the environment. The first aim of this project is to test predictions of
this model using high resolution functional magnetic resonance imaging (fMRI) in paradigms requiring integration
of information across experiences. The results will clarify fundamental mechanisms of how we learn novel
structure, adjudicating between existing models of this process, and informing further model development. There
are also competing theories as to the eventual fate of new hippocampal representations. One view posits that
during sleep, the hippocampus replays recent information to build longer-term distributed representations in
neocortex. Another view claims that memories are directly and independently formed and consolidated within
the hippocampus and neocortex. The second aim of this project is to test between these theories. We will assess
changes in hippocampal and cortical representations over time by re-scanning participants and tracking changes
in memory at a one-week delay. Any observed changes in the brain and behavior across time, however, may be
due to generic effects of time or to active processing during sleep. The third aim is thus to assess the specific
causal contributions of sleep to the consolidation of structured information. We will use real-time sleep
electroencephalography (EEG) to detect the peaks of slow oscillations, when endogenous replay is known to
occur, and play sound cues to bias memory reactivation. We will also expand our neural network model to
examine how offline hippocampal replay of recent regularities can shape distributed representations in
neocortex, providing a mechanistic account of offline consolidation of structured information. We expect that this
work will clarify the anatomical substrates and, critically, the nature of the representations that support encoding
and consolidation of novel structure in the environment. Having a robust, neurally grounded model of these
processes will help connect research in this area across laboratories and provide a framework for evaluating
what goes wrong in mental health disorders like depression and schizophrenia that involve profound
disturbances in learning and sleep.

Public health relevance
Project Narrative Behaving adaptively in our environment requires noticing the patterns around us and storing the learned information for long-term use. This project examines how the brain can quickly and effectively encode these patterns and how it then processes and solidifies this new information across time and sleep. A detailed understanding of these mechanisms could suggest new targets for intervention in mental health disorders such as depression and schizophrenia with profound disturbances to learning and sleep.